Memory guided planning across the lifespan

PROJECT SUMMARY
Throughout life, we routinely make decisions that impact our physical and financial health (e.g., which life
insurance plan to choose or whether to get a medical treatment). Our ability to make appropriate future
decisions depend, at least in part, on accurate memory for past choices, including memory for the context in
which those decisions were made. Older adults are impaired at these flexible, context-specific decisions. To
what extent is this related to their memory? Memory precision declines with age; this is true both of memory for
specific details of individual items (item memory) as well as memory for which items occur when and where
(context memory), and also how individual items and concepts are related to one another (statistical learning).
These declines are significantly more pronounced in individuals diagnosed with Alzheimer’s disease and
related dementias. This R01 proposal from two New Investigators aims to understand how memory failures
lead to decision failures. We will examine this question using a synergistic computational and neurobiological
approach. Specifically, we will measure the influence of different kinds of memories – item, context, statistical
learning - on choices, using novel computational frameworks we have developed, and variants of
well-validated tasks tuned to test these formal hypotheses. We will relate this framework to measures in
behavior, functional neuroimaging, and advanced diffusion imaging methods which we have also recently
developed. Although numerous studies have attributed choice performance to the striatum, fewer have
assessed the specific contributions of the medial temporal memory circuit. To address these limitations,
cognitively normal older adults will complete our decision tasks while undergoing functional and diffusion
magnetic resonance imaging (MRI) to assess contributions of the striatal and medial temporal circuits.
Extending our recent work, we will test for unique contributions of recent reinforcement and memory content
(item, context) and specificity (lure discrimination) to choices in older adults and whether the effect of memory
on choice performance relates to functional markers of context reinstatement in medial temporal cortex, and
structural markers of fronto-striatal and fronto-temporal circuit integrity in older adults (Specific Aim 1). We will
then assess how memory specificity influences the ability to build cognitive models or relationships among
stimuli and their outcomes, as well as relationships between this ability to infer structure and adaptive planning
(Specific Aim 2). Finally, we will test a novel intervention designed to improve planning decisions by training
individuals in a manner matched to their memory abilities (Specific Aim 3). Taken together, this project will
provide a novel, precise characterization of memory-guided decision performance in aging, a crucial first step
to identifying early biomarkers of age-related cognitive decline and related disorders.

Public health relevance
Project Narrative Both decision making and episodic memory decline in cognitively normal older adults, as well as those diagnosed with Alzheimer’s Disease and related dementias (ADRD). We will investigate whether the declines in decision making with age are related to specific cognitive and neurobiological components of memory decline. Examining these effects in young and old adults with a range of memory ability, this work will reveal novel behavioral and neural markers that will inform future interventions aimed at promoting decision success in older adults and provide earlier discrimination of cognitively normal aging from ADRD.